Endogenous Retroviruses and Alcohol Use Disorder

Project Summary/Abstract
Alcohol use disorder (AUD) is characterized by uncontrollable alcohol consumption due to physical and
psychological dependence. It poses a significant public health issue, affecting approximately 14.1 million
Americans and resulting in an annual economic burden of $249 billion. Despite the alarming rise in deaths and
economic costs, pharmacological treatment options for AUD have advanced only minimally since 2004,
underscoring the urgent need for novel therapeutic targets. Increased interferon signaling and activation of
inflammatory pathways have been established in both individuals with AUD and alcohol-preferring animals.
However, the mechanisms to reverse or modify these neuroimmune abnormalities remain inadequately
understood. Thus, there is a critical need to identify new neurobiological factors for potential intervention.
Endogenous retroviruses (ERVs) represent a promising area of investigation due to their roles in modulating
immune responses and contributing to inflammation. Comprising 8% of the human genome, ERVs consist of
more than 400,000 distinct elements derived from ancient retroviral infections integrated into human genomes.
These sequences can disrupt host cell functions and may reactivate in response to various environmental
triggers, including alcohol. Our proposed ERV-AUD model suggests that, although typically silenced, specific
ERVs can be transcriptionally activated by alcohol exposure, leading to inflammatory immune dysregulation in
AUD. We aim to investigate the role of ERV expression and ERV genotypes in the pathophysiology of AUD
through our innovative ERVcaller platform, which enables precise genotyping and expression quantification of
individual ERVs. Utilizing existing RNA sequencing and genome sequencing datasets from AUD patients, we
will pursue two Specific Aims: (1) to identify distinct ERVs whose expression correlates with AUD, and (2) to
identify ERV variants (rather than SNPs in ERV sequences) whose genotypes are associated with AUD.
Leveraging large datasets, innovative analytic tools, and high-performance computing resources, our analyses
will enable comprehensive genome-wide assessments of the full spectrum of the ERV landscape. Anticipated
outcomes include the identification of transcriptionally activated ERV transcripts and associated ERV variants
that could serve as novel biomarkers for AUD. This research has the potential to inform future therapeutic
strategies by elucidating ERV-related inflammatory pathways for targeted treatments, including repurposing
FDA-approved anti-retroviral or anti-inflammatory drugs, or developing new agents aimed at mitigating ERV-
driven inflammation in AUD patients. Establishing the connection between ERVs and AUD will provide focus
and supportive data for subsequent in-depth studies at the R01 level.

Public health relevance
Project Narrative Alcohol use disorder (AUD) is a pervasive public health issue in the United States and worldwide, yet existing approved pharmacotherapies for AUD are only partially effective. This project aims to identify endogenous retroviruses (ERVs) whose expression or genotypes are associated with AUD and related phenotypes. Establishing a connection between ERVs and AUD could lead to breakthroughs in anti-retroviral or anti- inflammatory treatments that may mitigate the effects of ERVs and potentially reverse the disorder.